Sensitive and spatially-selective quantification of oxygen in the headspace of pharmaceutical vials

Project Summary/Abstract
Physical Sciences Inc. (PSI) is developing a head space analyzer (HSA) to accurately measure 0.01%
of O2 in the head space of pharmaceutical vials at a speed of 600 vials per minute. The measurement
approach is non-destructive and selectively measures only oxygen in the vial head space. HSA is used in
the pharmaceutical industry to evaluate the closed container integrity (CCI) of packaging against air
ingress. The presence of oxygen in the head space indicates compromised packaging of a drug product,
potentially reducing the shelf life and efficacy and voiding the sterility. This is particularly true for biologic
drugs, the fastest growing pharmaceutical market segment valued at $90B/year, that are highly susceptible
to oxygen-induced degradation. The current standard for non-destructive HSA is based on laser
absorption spectroscopy. Laser-based HSA requires an active nitrogen purge to mitigate the signal
contribution of ~20% oxygen present in room air. The reliability of head space measurements with laser-
based HSA critically relies on the efficacy of a nitrogen purge. PSI's proposed HSA approach does not
require a nitrogen purge removing a mode of failure, and will be an order of magnitude more sensitive than
conventional laser-based HSAs. More sensitive detection of oxygen will lead to improved product shelf-life
and a reduction in the shortages of biologics and other classes of drugs that are vulnerable to oxidation.
During the Phase I program PSI will demonstrate the feasibility of the new HSA approach in a series of
benchtop experiments with standard pharmaceutical vials of different sizes. These studies will
demonstrate the capability of the technology to selectively quantify oxygen to 0.01% levels in the vial head
space with detection limits better than what are achieved with conventional laser-based HSAs. The
experimental studies will also demonstrate the capability of the HSA approach to be operated without an
active nitrogen purge. Knowledge gained from the Phase I studies will guide the development of a
fieldable prototype design to be fabricated during the Phase II program. In the Phase I program PSI will
establish a collaboration with a company that manufactures and sells vial inspection instrumentation. The
industry collaborator will provide a location for field testing of a prototype system fabricated in the Phase II
program.

Public health relevance
Project Narrative The proposed R&D effort will result in a sensor capable of non-destructive and selective measurement of oxygen in the head space of vials. The sensor will be used to ensure the container closure integrity of drug packaging preserving the sterility and shelf life of medications. The sensor will help pharmaceutical companies increase product shelf-life and reduce shortages of biologics and other classes of drugs.